The role of Calbindin in developmental and transplant-reactivated cortical plasticity

PROJECT SUMMARY/ABSTRACT
Critical periods are restricted windows of heightened plasticity during which developing neural circuits are
particularly sensitive to sensory input. Unlike the transient alterations that come with adult plasticity, changes
occurring during developmental critical periods are lasting and cemented after closure. The transplantation of
inhibitory progenitors into adult amblyopic mouse visual cortex has been shown to reactivate critical period
plasticity and rescue visual deficits. Recent findings suggest that this reactivation stems from the transplant-
induced developmental rejuvenation of host inhibitory neurons. The preliminary transcriptional profile of
rejuvenated host inhibitory neurons identifies Calbindin (Calb1), an understudied plasticizing molecule, as a key
upregulated factor. The long-term goal of this work is to investigate the role of Calb1 in the transplant-
induced rejuvenation of host inhibitory neurons and subsequent reactivation of critical period plasticity.
Aim 1a tests whether Calb1 is necessary for transplant-reactivated plasticity by virally-inactivating Calb1 function
in recipient adults and using intrinsic signal optical imaging to assess for a shift in ocular dominance following
monocular deprivation. To test whether Calb1 is necessary for developmental critical period plasticity, the same
approach will be applied to non-transplanted juveniles. Aim 1b tests whether Calb1 is sufficient to reactivate
plasticity, non-transplanted adults with virally-overexpressed Calb1 show shifts in ocular dominance post-
monocular deprivation. Aim 2a utilizes weighted gene co-expression network analyses of the previously
generated transcriptional data to identify the biological pathways underlying transplant-induced rejuvenation.
Expression of identified pathway components will be validated and characterized in Aim 2b using
immunohistochemistry. This work will yield novel insight into the cell and molecular mechanisms underlying
inhibitory neuron transplantation, visual circuit development, and reveal new translatable targets for the
development of neurotherapeutics. Brain repair strategies that catalyze endogenous cellular rejuvenation hold
great clinical promise for a broad range of neurological and neuropsychiatric disease.
The technical aspect of my training plan focuses on the acquisition of viral injection and functional imaging (Aim
1), and bioinformatic and statistical analysis skills (Aim 2). Aim 1 training will be carried out under sponsor and
visual neurophysiologist Dr. Gandhi and postdoctoral fellow Dr. Figueroa-Velez, and Aim 2 training will be guided
by co-sponsor and transcriptomics expert Dr. Spitale and bioinformatician Dr. England. Technical training will be
complemented by a heavy emphasis on scientific communication, professional development, teaching, and
outreach. UC Irvine is a rich, well-established training ground for successful graduate students and offers a
breadth of resources, structured courses, and networking opportunities.

Public health relevance
PROJECT NARRATIVE/RELEVANCE Dysfunction of GABAergic inhibitory circuits has been implicated in many neurodevelopmental and neuropsychiatric disorders, such as amblyopia, epilepsy, and schizophrenia. This proposal aims to determine the role of Calbindin, an understudied plasticizing molecule, in reactivating developmental plasticity in adult inhibitory neurons. By elucidating the cell and molecular mechanisms underlying this rejuvenation, our work may open novel therapeutic avenues for brain repair.